Administrative Core

PROJECT SUMMARY
The Administrative and Leadership Core, Core A, of the Program Project “Alzheimer's Disease and Related
Disorders Treatment and Outcomes in America: Changing Policies and Systems” will provide the leadership
and organizational structure to support and promote the scientific mission of the overall Program Project.
Core A provides the scientific and administrative direction to the various projects and cores through a
Steering Committee of investigators, assisted by a National Advisory Committee. Core A maintains internal
communication among investigators and committees, including maintenance of meeting minutes, schedules,
and status reports as well as external communication with federal officials and other constituents interested in
project findings. Core A also maintains and updates the P01 website, www.LTCFocus.org, which
disseminates research findings and de-identified project data. Additionally, Core A integrates students, pre-
and post-doctoral fellows with aging and health services research interests into the research team to expand
the use of project data to a broader pool of interested users. Core A is also responsible for administrative
support, including budget preparation, appropriate allocation of funds and monitoring of expenditures,
initiation and management of contracts and consulting agreements, preparation and submission of annual
reports, assurance of compliance with human subjects, scientific integrity, and financial policy requirements of
the NIH, submission of Data Use Agreements with the Centers for Medicare and Medicaid Services (CMS)
and meeting CMS reporting and dissemination requirements, and finally for liaison with and dissemination to
external stakeholders and partners.